Understanding and supporting cancer survivorship needs of children with Down syndrome in remission from leukemia and their families

PROJECT SUMMARY
Children with Down syndrome (DS) are 56 times more likely to be diagnosed with leukemia compared to children
without DS. More than 85% of all children diagnosed with cancer will survive more than 5 years but experience
late effects from the cancer treatment impacting quality of life. In addition, children with DS have unique physical
and psychosocial implications when reintegrating into meaningful activities. Caregivers play a critical role in
advocating for their child and are essential to facilitate participation. However, the limited available reintegration
research has primarily focused on children without DS, neglecting the unique social and health needs for daily
participation and quality of life specific to those with intellectual and developmental disabilities. As the population
of childhood cancer survivors grows, there is a critical need to move beyond describing the late effects of cancer
in children with DS but to also support reintegration into daily activities in the home, school, and community
environments to improve long-term developmental outcomes and quality of life for both the child and family. The
goal of the F99 phase of my proposal is to understand the needs of children with DS and their families once in
remission from leukemia. I will use a convergent mixed methods approach to understand the relationship
between late effects of cancer (cognition, behavior, and health outcomes) in children with DS and mental health
of the caregivers (n=15 family dyads) during reintegration experiences. The F99 phase will provide essential
insight into the needs of children with DS and families to understand what the barriers and facilitators are to
reengaging in meaningful activities once in remission. For the K00 phase of my proposal, I will develop and
implement, in collaboration with stakeholders, an evidence-based and family-centered intervention toolkit, to
support childhood cancer survivors, tailored to children with DS. Aim 2 will use a community-engaged approach
to develop an intervention toolkit to support reintegration for children with DS and their families after leukemia
back into meaningful home, school, and community activities. The intervention will be piloted on 15 families to
evaluate acceptability and effectiveness using goal attainment scaling to allow families to prioritize family-
centered individualized goals. The fellowship development plan will provide additional training in eight areas; a)
understanding of DS and cancer survivorship; b) assessments of cognition, adaptive behavior, and health
outcomes; c) qualitative analysis, d) mixed methods analysis, e) stakeholder engagement and community-based
participatory research, f) mentorship and professional development; g) scientific writing and dissemination, and
e) responsible conduct of research. My ultimate goal is to become a tenured professor and run an
independent externally funded research lab that includes family and community partners to address the
unique reintegration needs among leukemia survivors in children with Down syndrome and their
families.

Public health relevance
PROJECT NARRATIVE Children with Down syndrome (DS) are at an increased risk of developing leukemia and have unique developmental and health needs that impact the child’s needs once in survivorship. As the population of childhood cancer survivors grows, there is a critical need to move beyond describing the late effects of cancer in children with Down syndrome but to also support reintegration into meaningful daily activities in the home, school, and community environments. The proposed research will provide insight and create a tailored stakeholder-informed intervention to meet the unique survivorship needs of children with Down syndrome and their families to improve long-term developmental outcomes and quality of life for both the child and family.